Composition and formation of the cyst wall

ABSTRACT: Toxoplasma gondii is a ubiquitous Apicomplexan protozoan parasite of mammals and
birds. It is unusual in that propagation does not require passage through its definitive host enabling T.
gondii to propagate clonally through its intermediate hosts. T. gondii causes congenital infections in
immune competent hosts and opportunistic infections in immune compromised hosts. The predilection
of this parasite for the central nervous system causing necrotizing encephalitis and for the eye causing
chorioretinitis constitutes its major threat to patients. The development of these diseases is a
consequence of the transition of bradyzoites, found within tissue cysts into actively replicating
tachyzoites. It is believed that tissue cysts are not static structures, but regularly rupture reinvading new
host cells. It is likely that in chronic toxoplasmosis, i.e. latent infection, tissue cysts within host cells,
regularly transform to tachyzoites which are removed or sequestered by the immune system.
Degenerating cysts are often seen in the brains of mice with chronic toxoplasmosis. Such a dynamic
equilibrium between encysted and replicating forms leads to recurrent antigenic stimulation and the
persistent antibody titers found in chronically infected hosts. The widespread distribution of T. gondii in
humans and other animals is due to the ability of tissue cysts to permit oral transmission of this infection.
The cyst wall is the critical structure for survival, reactivation and transmission of T. gondii.
Understanding T. gondii developmental biology and formation of the cyst wall will inform strategies such
as vaccine development and therapeutic agents to eliminate latency and prevent reactivation
toxoplasmosis. Several lines of evidence suggest that bradyzoite differentiation is stress mediated
and that the cyst wall (a modified parasitophorous vacuole membrane) contains many stage specific
proteins and glycoproteins. Our laboratory group has identified several cyst wall specific proteins
several of which have mucin type domains that are o-glycosylated and demonstrated that
glycosylation is important for cyst wall stability. CST1, a cyst wall glycoprotein, appears to be a
scaffolding protein for formation of the cyst wall and we hypothesize that other cyst wall proteins
interact with CST1 in establishing the cyst wall. Our laboratory group has developed techniques to
purify the cyst wall enabling proteomic characterization of this structure as well as adapted BirA
tagging techniques to enable definition of the cyst wall interactome. Furthermore, we have
established ppGalNAcTs knockout T. gondii strains that enable studies on the role of o-glycosylation
in cyst wall formation. An integrated approach employing proteomic, immunologic and genetic
techniques will be used to fully characterize the T. gondii cyst wall proteome and the importance and
interactions of the identified cyst wall components. The improved understanding of the formation of
the cyst wall provide by these studies will provide the basic underpinnings of new strategies to
eliminate latent infection thereby preventing reactivation toxoplasmosis.

Public health relevance
PUBLIC HEALTH RELEVANCE: Toxoplasma gondii is a pathogen of both immune competent and immunocompromised humans that is transmitted by contaminated food and water. It can also cause congenital infections with mental retardation. The tissue cyst surrounded by a cyst wall is critical for transmission and reactivation of this infection. Investigations on the formation of the cyst wall should help define new approaches to control of this pathogenic protozoan.